Alcohol Dependence: Integrating Genetic & fMRI Methods

DESCRIPTION (provided by applicant): Efforts to develop more effective treatment approaches for alcohol dependence will benefit from two lines of research: 1) a more precise characterization of the neurobiological mechanisms that underlie responses to alcohol cues and relapse; and 2) the identification of biomarkers (e.g., genetic variations) that reflect the functional significance of these mechanisms on an individual level, such that they might be used to match individuals with the treatment most likely to be effective for them. Consistent with these two overarching objectives, our focus over the last five years of support has been to integrate neuroimaging and genetic approaches to more precisely characterize the neurobiological mechanisms that putatively underlie reactivity to alcohol cues and to identify biomarkers associated with those mechanisms. The focus of data analyses to date has been the characterization of fMRI BOLD response to the presentation of alcohol cues (i.e., the taste of alcohol) and genetic variations that predict that response in a sample of 270 individuals with an alcohol use disorder. The results (see preliminary studies section) provide strong initial support for 100 single nucleotide polymorphisms (SNPs) that are associated with cue-elicited BOLD response in the striatum and prefrontal cortex. The overarching aim of this application for continuation of funding is to follow-up these analyses with an a priori hypothesis driven study designed to replicate individual SNP results. The research will also examine years of heavy alcohol abuse as an environmental variable that may interact with genetic variation to exacerbate changes in neuronal function in a sample of 320 individuals with alcohol use disorders.

Public health relevance
PUBLIC HEALTH RELEVANCE: This research combines neuroimaging and genetic approaches to examine how specific genetic variations are related to responses to alcohol cues. This research will also test whether the number of years of heavy alcohol exposure interacts with specific genetic variations to predict how people respond to alcohol cues. Improvements in our understanding of genetic factors and neurobiological mechanisms that influence the etiology of alcohol dependence is expected to have implications for new prevention and treatment approaches. This research combines neuroimaging and genetic approaches to examine how specific genetic variations are related to responses to alcohol cues. This research will also test whether the number of years of heavy alcohol exposure interacts with specific genetic variations to predict how people respond to alcohol cues. Improvements in our understanding of genetic factors and neurobiological mechanisms that influence the etiology of alcohol dependence is expected to have implications for new prevention and treatment approaches. __SpecificAimsTextDelimiter__ Specific Aims Current pharmacological and psychosocial approaches to the treatment of alcohol dependence may best be described as modestly effective. Given the substantial heterogeneity in the biological and psychosocial mechanisms that underlie the development of dependence and the inability to maintain abstinence, it is unrealistic to expect that current efforts will lead to the development of a "magic bullet" for the treatment of alcohol dependence. Rather, there will likely be a number of treatment options, each of which targets slightly different mechanisms. Thus, efforts to develop more effective treatment approaches will benefit from two lines of research: 1) a more precise characterization of those neurobiological mechanisms that underlie relapse; and 2) the identification of biomarkers (e.g., genetic variations) that reflect the functional significance of these mechanisms on an individual level, such that they might be used to match individuals with the treatment most likely to be effective for them. Consistent with these two overarching objectives, our focus over the last five years of support has been to integrate neuroimaging and genetic approaches to more precisely characterize the neurobiological mechanisms that putatively underlie reactivity to alcohol cues and to identify biomarkers associated with those mechanisms. The last 5 years of effort yielded a sample of n=319 individuals with an alcohol use disorder, each with detailed clinical information (e.g., history of substance use and comorbid psychopathology), neuroimaging information (fMRI, sMRI, DTI), genetic information (e.g., >1 million single nucleotide polymorphisms and >2000 copy number variations) and epigenetic information (>27,000 CpG methylation sites). The focus of data analyses to date has been the characterization of fMRI BOLD response to the presentation of alcohol cues (i.e., the taste of alcohol) and genetic variations that predict that response. After accomplishing the aims of the original study to examine specific candidate genes (e.g., Hutchison et al., 2008), exploratory analyses were conducted on approximately 792,000 single nucleotide polymorphisms (SNPs). The results (see preliminary studies section) provide strong initial support for 100 SNPs that are associated with cue-elicited BOLD response in the striatum and prefrontal cortex. The overarching aim of this application for continuation of funding is to follow up these exploratory analyses with an apriori hypothesis-driven study designed to replicate associations between the SNPs and BOLD response in the striatum and prefrontal cortex after exposure to alcohol cues. The research will also examine years of heavy alcohol use as an environmental variable that may interact with genetic variation to influence neuronal function. Finally, the proposed research also includes new exploratory analyses designed to extend the initial findings with greater statistical power. While not an explicit aim of this proposal, we are actively integrating the findings from this line of research with clinical studies (e.g., our own clinical studies as well as national multi-site trials such as Project COMBINE) to address the clinical implications of this more basic line of research. The specific aims and hypotheses are as follows: 1. The first aim is to conduct a replication study by testing whether 100 SNPs advanced in our preliminary studies are associated with BOLD response to alcohol cues, as compared to appetitive control cues. To that end, 320 individuals with an alcohol use disorder will be genotyped on the 100 SNPs identified in our initial study and will then participate in our alcohol cue exposure fMRI paradigm. " Hypothesis 1. Based on our exploratory findings that suggest an association between genetic variation and BOLD response after alcohol cue exposure (as compared to control cue exposure), it is expected that these SNPs will be associated with significant activation of the anterior cingulate, dorsal and ventral striatum, and insula after exposure to alcohol cues, after correction for multiple comparisons. 2. The second aim is to extend the line of research by testing whether years of heavy alcohol use, as an environmental variable, interacts with genetic variation to influence neuronal function. " Hypothesis 2. Based on the premise that some SNPs may be associated with cue-elicited BOLD response because they accelerate (or mitigate) the effects of heavy alcohol exposure on neuronal adaptations, it is expected that a subset of SNPs will demonstrate a significant interaction with number of years of heavy alcohol use on BOLD response to alcohol cues in the striatum and prefrontal cortex (PFC). . " Hypothesis 3. Based on the premise that some SNPs may have a premorbid impact on neuronal function, that in turn may be a risk factor for heavy use, it is expected that a subset of SNPs will demonstrate only a main effect, with no significant interaction with number of years of heavy alcohol exposure. 3. The third aim is to identify additional subsets of genetic variations, and more broadly, additional molecular networks associated with cue-elicited responses in the striatum and prefrontal cortex by applying the analysis strategy presented in the preliminary studies section to a much larger sample (i.e., the sample from the initial 5 year period of support combined with the sample from the current application). " Hypothesis 4. Given a major increase in statistical power that can be achieved by increasing the sample size of the initial sample, it is anticipated that these exploratory analyses will identify several additional molecular networks, in addition to the glutamate signaling pathway identified in the preliminary analyses. It is important to note that the proposed research is expected to have a significant impact on the literature. Simply put, the research is innovative. There are no published reports on genome wide studies with neuroimaging data, much less reports that are focused on alcohol use disorders. The proposed research is significant because it has the potential to advance new biomarkers that can be tested as predictors of relapse in treatment outcome studies. The research has the potential to uncover new molecular mechanisms that may be useful pharmacological targets in future studies. The preliminary studies section provides strong support for the potential significance of the findings as well as the feasibility of the approach. And finally, data sharing will expand the significance of the research by making a wealth of data (fMRI, sMRI, DTI, SNPs, CNVs) available to other investigators, which will facilitate the replication of genetic findings uncovered in other investigations.